Troponin I serine 150 phosphorylation as a novel cardiac inotrope

ABSTRACT
Heart failure, defined simply as the inability of the heart to pump blood to meet the needs of the body, is a
leading cause of death in the United States and worldwide. Current therapies for systolic dysfunction prolong
the procession of disease, but do not treat the cause of disease: reduced contractility. Earlier attempts to
increase contractility using positive inotropes failed because they increased contractile force by increasing
intracellular calcium concentration. An alternative mechanism to increase cardiac contractility without elevating
calcium concentrations is to increase the sensitivity of the myofilament to calcium. We previously demonstrated
that, at the muscle level, increasing phosphorylation of Ser150 on the myofilament protein troponin I (TnI)
increases contractile force due to increased calcium sensitivity. To investigate this effect in vivo, have
developed TnI Ser150 phosphorylation and TnI Ser150 phosphorylation null mouse lines. Echocardiography
data demonstrates that TnI Ser150 phosphorylation mice have increased systolic function without detrimental
diastolic dysfunction or hypertrophy. Our central hypothesis is that increasing TnI Ser150 phosphorylation will
improve cardiac function by increasing contractility and that increasing TnI Ser150 phosphorylation will be
beneficial in recovering cardiac function during heart failure. Aim 1 will explore if TnI Ser150 phosphorylation
increases systolic function by increasing contractility without increasing calcium making TnI Ser150
phosphorylation a novel positive inotrope. We will use invasive in vivo cardiovascular functional measurements
to quantify contractility and cardiac reserve and culture human induced pluripotent stem cell cardiac myocytes
(hiPSC-CMs) to measure cellular function and calcium transients. Aim 2 will confirm that increasing TnI
Ser150 phosphorylation is beneficial for cardiac function during heart failure. We will subject TnI Ser150
phosphorylation, TnI Ser150 phosphorylation null, and wildtype mice to myocardial infarction surgeries and
assess cardiovascular function after pathological stress. Together, successful completion of these aims will
support TnI Ser150 phosphorylation as a novel cardiac inotrope that improves contractility and cardiac function
during heart failure.

Public health relevance
NARRATIVE Heart failure resulting from a loss of cardiac contractility remains a major cause of death in the United States and worldwide. This proposal explores a new approach to improve heart function by increasing the phosphorylation modification of the cardiac regulatory protein troponin I to increase contractility. We will use mouse models, real-time assessments of cardiac structure and function, and human cardiac myocytes to explore the role of this modification during heart failure.